Next-Generation CNS-Penetrant HDAC6 Inhibitors: Proof-of-Principle in Parkinson's Disease

Summary: Parkinson’s disease (PD) is a progressive neurodegenerative disorder characterized by loss of do-
paminergic neurons (DANs) leading to severe motor and non-motor symptoms. Despite the availability of dopa-
mine replacement therapies, there remains a critical need for disease-modifying treatments that can address the
underlying pathologies of PD. Recent research suggests overactivity of histone deacetylase 6 (HDAC6) as a
contributing factor in the pathogenesis of PD. HDAC6 deacetylates key cytoplasmic proteins like alpha-tubulin
and tau, and both are hypoacetylated in PD, supporting HDAC6 hyperactivity. HDAC6 inhibition has shown
promise in preclinical models, demonstrating protective effects against alpha-synuclein toxicity, oxidative stress,
and neuroinflammation, thereby enhancing DAN survival. Yet, the development of HDAC6 inhibitor therapeutics
has been limited by challenges in achieving potency, selectivity, brain penetrance, and demonstrable target
engagement in the human brain. Eikonizo is developing a new class of potent, selective, and brain-penetrant
HDAC6 inhibitors, overcoming previous limitations and introducing promising candidates for disease-modifying
PD therapy. The proposed Phase I SBIR project aims to evaluate the efficacy of Eikonizo development candi-
date EKZ-102 in reducing pathological markers of PD and improving DAN survival in both in vitro and in vivo
models through the following Specific Aims: 1) establish proof-of-principle of EKZ-102 for treatment of PD in vitro
by assessing impact on alpha-synuclein pathology, oxidative stress, and DAN survival in rodent and human
iPSC-derived DAN cultures; and 2) define the therapeutic potential of EKZ-102 in an animal model of PD featur-
ing striatal alpha-synuclein preformed fibril lesion to mimic key aspects of PD pathology. The successful com-
pletion of the proposed project will validate the disease-modifying potential of EKZ-102 inhibitors in preclinical
models, setting the stage for an FDA pre-IND meeting and completion of IND-enabling studies.

Public health relevance
Narrative: Parkinson’s disease (PD) poses a significant societal and economic burden, being second only to Alzheimer’s Disease (AD) for neurodegenerative disorders that lead to increased disability, increased healthcare costs, and decreased quality of life for both patient and caregiver. The proposed project will develop a novel therapeutic class of HDAC6 inhibitors for PD treatment that overcome the shortcomings of other approaches through development of a unique inhibitor with properties more amenable to drug success. This approach targets underlying mechanisms which could alleviate motor performance symptoms and modify the disease course, offering a more effective treatment option with the potential to enhance health outcomes for those affected by PD.